Off-label drugs in cardiology: evaluating age- and disease-appropriate therapies

Project Summary
Off-label medications are widely used in the clinical care of pediatric patients, with disproportionate use in
cardiovascular subspecialties. More than 75% of children with cardiovascular disease receive at least one off-
label medication. Further, congenital heart disease (CHD) patients requiring surgical repair are likely to receive
multiple off-label therapies, including antiarrhythmics (76% of prescribed medications), beta-blockers (97%),
adrenergic agents (85%) and Ca2+ channel blockers (96%). Since pediatric CHD populations are
underrepresented in preclinical and clinical studies, practitioners often rely on empirical data or adult data to
guide off-label prescription choice and/or extrapolate dosing regimens. As a result, cardiovascular drugs are
administered off-label to neonates, infants, and children with little consideration of myocardial immaturity. Indeed,
many cardiovascular medications have been shown to exert variable age-dependent outcomes and/or
undesirable adverse effects. A physiology-driven approach is urgently needed to inform and optimize age-
appropriate therapies for CHD patients, particularly in the neonatal – adolescent period when the myocardium
undergoes rapid adaptive changes.
In the proposed application, we will test the hypothesis that myocardial immaturity perturbs cardiac drug
responsiveness, as ion channel expression, calcium handling, and dopamine/adrenergic drug targets are
underdeveloped. Using innovative techniques, including large animal models and human cardiac tissue procured
during surgery, optical mapping of voltage and intracellular calcium, computational models, and transcriptomic
and proteomic profiling, we will address the following aims: 1) Determine the extent to which postnatal
development alters the transcriptomic, proteomic, and anatomical profile of the myocardium. 2) Investigate
pharmacodynamic responses to off-label antiarrhythmic and inotropic drugs in neonatal – juvenile hearts, in the
context of cardiopulmonary bypass (CPB). 3) Evaluate the impact of myocardial immaturity on clinical
responsiveness to drug therapies in CHD patients. This study addresses the objectives of PAR-20-300 by
establishing data on developmental pharmacodynamics using highly translational cardiac models and
mathematical modeling approaches. Results will inform clinical care decisions for CHD patients by providing
evidence on the safety, efficacy, and potency of antiarrhythmics and inotropes. Moreover, the methods and
models within this study are scalable to other drug therapies used in pediatric cardiology. Completion of this work
will enhance our understanding of postnatal cardiac development in the context of CHD, which can promote
tailored pharmacotherapies that are age- and disease-appropriate.

Public health relevance
Project Narrative Congenital heart disease (CHD) affects 1% of live births, with one quarter of cases requiring surgical correction in the first year of life. More than 75% of CHD patients receive off-label cardiovascular medications to manage postoperative arrhythmias and low cardiac output. We will investigate the impact of myocardial immaturity on cardiac drug responsiveness, using both large animal models and cardiac tissue procured from CHD patients.